Molecular mechanisms of a neurodevelopmental seizure disorder

Project Summary
Disrupting neurodevelopmental processes leads to a range of neurological, psychiatric and behavioral
disorders. In the US, one in six children exhibit some form of neurodevelopmental disorder, ranging from
severe dysfunction to mild social-behavioral difficulties. Genetics plays a critical role and many genes have
been implicated as risk factors for diverse neurodevelopmental disorders. However, common themes that are
shared by multiple neurodevelopmental disorders include disturbances to the autophagy-lysosome pathway
and the dysregulation of mTORC1 kinase signaling. A common co-morbidity of neurodevelopmental disorders
with mutations affecting the autophagy-lysosome pathway and mTORC1 dysregulation are seizures, implying
that these fundamental cellular processes also underlie an imbalance in excitatory and inhibitory activities. The
goal of this project is to uncover a new molecular connection between the autophagy-lysosome pathway and
mTORC1 dysregulation that leads to neurodevelopmental disorders and epilepsy. In yeast we found that the
yeast Kctd (Whi2 protein/Whi2p) is a potent negative regulator of TORC1 and is required for induction of
autophagy in low nutrient conditions. Based on findings from yeast models, we identified mammalian
counterparts as a family of understudied human genes known as the potassium channel tetramerization
domain proteins (KCTDs). The long-established binding partners of yeast Kctd (Whi2) are the yeast protein
phosphatases Psr1 and Psr2, which have obvious human homologs, the CTDSP/CSP phosphatase family. We
will test the hypothesis that KCTD family proteins are regulators of a protein quality control pathway that is also
connected to the mTORC1 signaling pathway. Several KCTD family members have been linked to
neurodevelopmental disorders including epilepsies, autism and schizophrenia. We propose to translate our
unique insights gained from studies in yeast to delineate an important molecular mechanism of pathogenesis in
the brain using cellular and biochemical approaches and a mouse model that recapitulates important aspects
human disease.

Public health relevance
PROJECT Narrative Neurodevelopmental disorders are common and are generally considered to be incurable, but could be ameliorated with more detailed understanding of the underlying processes. We propose to apply discoveries made in a model organism to delineate new mechanisms of human neurodevelopmental disorders.